CORTISOL SECRETION IN ALZHEIMER'S DISEASE PROGRESSION

The purpose of this study is to determine if there is a relationship between cortisol secretion and the progression of Alzheimer's disease. Subjects are being studied over a period of 2 years and evaluated initially and at yearly intervals.